Cumulative effects of persistent organic pollutants and non-chemical stressors on child development

Project Abstract
The prevalence of neurodevelopmental delays in the United States has increased substantially over the last two
decades, possibly due to increased prenatal exposure to chemical and non-chemical stressors. Persistent
organic pollutants, or POPs, are man-made chemicals that are of health concern given their ubiquitous exposure,
persistence in the environment and human body, and transmission to offspring during pregnancy. For humans,
the most commonly encountered POPs include per- and polyfluoroalkyl substances (PFAS), polybrominated
diphenyl ethers (PBDEs), organochlorine pesticides (OCPs), and polychlorinated biphenyls (PCBs).
Psychosocial stress is also a major public health problem, due to its high prevalence, association with adverse
maternal and child health outcomes, and ability to amplify the adverse health effects of environmental chemicals.
Communities of color, particularly African Americans (AAs), experience the largest burden of POPs exposure
and are disproportionately exposed to non-chemical and psychosocial stressors. However, few studies have
examined chemical and non-chemical stressors together as an exposure mixture, despite our knowledge that
they co-occur and cluster around socioeconomic status. Leveraging an ongoing prospective birth cohort of
African American pregnant people and their children in Atlanta, Georgia, this study will examine the cumulative
effect of prenatal POPs and non-chemical stressors on delayed neurodevelopment in early infancy. The Atlanta
African American Maternal-Child cohort is a socioeconomically diverse and exceptionally phenotyped cohort that
recruits pregnant people during early pregnancy and is following offspring through age 5. This project will take
advantage of the rich biological and questionnaire data, as well as infant cognition assessments. Specifically,
my project will examine sociodemographic characteristics, home product and personal care product usage as
predictors of POPs exposure (Aim 1). This may illuminate interventions and practices aimed at reducing POPs
exposure and ultimately preventing adverse outcomes. In order to better characterize the prenatal exposome,
my analytical approach in Aims 2 and 3 will utilize methods designed for analyzing chemical exposure mixtures
to examine the combined effects of POPs and psychosocial stressors. I will examine the mixture effects of
prenatal exposure to four classes of POPs on infant neurodevelopment (Aim 2) and assess the combined effects
of POPs, racial discrimination, depression, anxiety, and perceived stress on infant neurodevelopment (Aim 3).
My long-term career goal is to become a leader in environmental health sciences, with a focus on maternal and
child health. To build on my previous pre-doctoral and post-doctoral research in perinatal and environmental
epidemiology, I will be mentored by Dr. Dana Barr, a leader in exposure assessment, as well as Drs. Carmen
Marist and Patricia Brennan, experts in studies of the exposome and child neurodevelopment, respectively. The
outstanding training opportunities in high-priority research areas with key leaders in the field will enhance my
skillset and position me well for a career as an independent investigator.

Public health relevance
Project Narrative Pregnant people are exposed to persistent organic pollutants (POPs) and non-chemical stressors which adversely impact maternal and child health outcomes, including cognitive development in offspring. African Americans, who disproportionally experience elevated rates of adverse maternal and child health outcomes, are also exposed to the highest levels of environmental hazards and social stressors. This research will leverage a prospective birth cohort of African Americans and will apply novel statistical methods to examine infant neurodevelopment in relation to a mixture of prenatal POPs and social stress exposures, better reflecting real-life exposure patterns.